Administration Core

Project Summary
CREATE involves a collaboration between three sites: Weill Cornell Medicine (WCM), Florida State University
(FSU), and U. of Illinois Urbana-Champaign (UIUC). Dr. J. Sharit. will remain as a research Co-leader and
member of the Executive Working Group (EWG), but data collection will not take place at the University of
Miami (UM). To increase our scientific and technical capacity, we also involve faculty from other campuses
within our institutions (e.g., Cornell Tech) and other institutions (e.g., Carle, Northwestern). CREATE has a
highly efficient and effective organizational structure, which consists of four integrated units: The Administrative
Core (AC), newly restructured Data and Technical Development Core (DTDC), the Dissemination Core (DC),
and the Research Program, which includes three thematic cross-site projects and a Pilot Research Program.
An External Scientific Advisory Board (ESAB), central Data Safety and Monitoring Board (DSMB), Community
Advisory Boards (CABs), and Industry Advisory Council (IAC; new for CREATE V) augment the Center. If
funded, the AC will continue to provide leadership for the Center and oversight and direction for its activities.
The AC will assume primary responsibility for ensuring that the Center’s science is of high quality and fostering
collaborations across the sites, the community and clinical settings, industry, government representatives, and
older adults. The AC will work to expand the Center’s research, development of junior investigators, and help
ensure that the Center’s outcomes are broadly disseminated. The aims of the AC are to: 1) provide leadership
and direction for the Center’s activities and oversight of progress; 2) facilitate cross-site collaborations and
integration across the research projects and the DTDC & DC; 3) facilitate linkages between the ESAB, CABs,
DSMB, IAC, and the NIH; 4) facilitate linkages with the community, government agencies, and industry; 5)
ensure adequate resource and technical support for the research and the DTDC & DC; 6) assist with
identification of participant recruitment/retention strategies and administration of the CREATE Core Battery of
Measures; 7) administer the Pilot Research Program; 8) promote and facilitate expansion of the Center’s
research and foster international collaborations; and 9) help ensure the Center is visible within the public policy
arena. The AC will build on our existing structures and protocols and long standing and newly formed
collaborative relationships. The Center’s evaluation plan has internal and external feedback loops and
includes: 1) monthly and annual reporting mechanisms; 2) tracking of research and core activities and
progress; and 3) reporting to the ESAB, CABs, DSMB, IAC, and the NIH. Our metrics will include traditional
markers of academic success (e.g., peer reviewed manuscripts, presentations) and metrics beyond
contributions to the academic knowledge base (e.g., training of junior scientists, inclusion of diverse samples;
relationships with community organizations and industry; development of guidelines and tools for technology
design; resource sharing, impact on technology design and older adults).